Inositol Supplementation to Treat Reproductive and Metabolic Dysfunction in Polycystic Ovary Syndrome: A Double Blind RCT (INSUPP-PCOS)

PROJECT SUMMARY ABSTRACT
Polycystic ovary syndrome (PCOS) is the most common endocrinopathy among women. It is a heterogeneous
syndrome with reproductive dysfunction of chronic anovulation and hyperandrogenism, as well as metabolic
dysfunction: insulin resistance, glucose intolerance and metabolic syndrome. One such medication that may
improve both aspects of PCOS is inositol and it is available throughout the world as a dietary supplement.
More specifically we will study a combination of isomers, d-chiro and myo-inositol. The combination is thought
to improve insulin (and gonadotropin) signaling by restoring an imbalance in inositolglycans which are second
messengers in cell surface signaling. This project is the first adequately powered and designed double-blind
randomized clinical trial to test prospectively the effects of inositol supplementation in a double blind study (the
INSUPP PCOS study). We are conducting a four-armed study of inositol: Inositol at 1 gm, 2 gm, 3 gm bid vs.
placebo bid over a 3 month period in 108 women with PCOS. The purpose of this supplement is for us to
complete the total enrollment count of 108 women. We want to successfully complete this project in order to
reach our study goals and specific aims, which remain the same. Identify the effect of inositol supplementation
on serum testosterone levels during the study. Hypothesis 1 (Primary Outcome): Women with PCOS who
receive inositol supplementation will have a significantly greater reduction in serum total testosterone than
women on placebo, as well as our secondary markers of hyperandrogenism: SHBG and the free androgen
index.

Public health relevance
PROJECT NARRATIVE Polycystic ovary syndrome (PCOS) is the most common endocrine abnormality in women in the U.S. and is characterized by both reproductive (anovulation and androgen excess) and metabolic dysfunction (insulin resistance). PCOS lacks a simple, safe and effective treatment for women of all ages and all weights. Recently a dietary supplement, inositol, has been used widely to treat women with PCOS. However there are no well- designed trials to address the risk/benefit ratio and identify the mechanism of action. In this study we are actively conducting a three month double blind (of both patients and investigators) randomized controlled trial of inositol supplementation compared to placebo. Our primary outcome is, women with PCOS who receive inositol supplementation will have a significantly greater reduction in serum total testosterone than women on placebo.